Human Phenotyping Core

Human Phenotyping Core Project Summary
The rapid development of new approaches to interrogate the immune and inflammatory systems comes
with a growing demand for both technical and conceptual expertise in these methodologies. The Human
Phenotyping Core was created to support these activities within the Oklahoma Rheumatic Disease Resources
Cores Center (ORDRCC). To address the most broadly scientifically interesting and clinically important
questions, our ORDRCC Investigators need access to cutting-edge approaches, such as scRNA-Seq/CITE-
Seq, ChipCytometry, and CyTOF to perform incisive experiments and to generate high-quality, reproducible
data. The Human Phenotyping Core will allow our investigators to ask novel questions regarding the molecular
phenotypes of rheumatic diseases. In addition to providing ORDRCC investigators with high-content
biomolecular phenotyping services, the Human Phenotyping Core in conjunction with the Clinical
Characterization and Biorepository Core (CCBC) will provide access to datasets containing previously
collected genetic, proteomic, and biomolecular phenotypes of clinical subjects whose samples are available
from the CCBC. The tight integration of the Human Phenotyping Core, CCBC and our databases will enable
investigators to efficiently phenotype samples and correlate molecular and cellular phenotypes with clinical
characteristics, to select more homogeneous patients for hypothesis-driven investigation and help provide the
foundational knowledge needed for precision medicine in rheumatic disease care.
By consolidating a range of technologies required for the complete characterization of molecular or
cellular phenotypes into a single unit, the Human Phenotyping Core (HPC) will streamline services to help
ORDRCC investigators in the efficient planning, design, execution and data analysis required for their
individual projects. The HPC will provide experience in performing research using clinical specimens,
technical expertise in a wide range of molecular and bioassays, access to equipment and resources thus
enabling cutting-edge approaches to address research questions, quality control assessment of the data
collected and data processing suitable for higher end statistical modeling of phenotype/clinical associations.
SPECIFIC AIM 1: Assist ORDRCC Investigators, JCIs and Scholars to navigate the stages of project
development, experimental design, resource planning and execution of translational and mechanistic studies
through Core Management and individual consultations.
SPECIFIC AIM 2: Provide access to advanced molecular phenotyping technologies and experienced
technical personnel for efficient execution of advanced experimental data plans.
SPECIFIC AIM 3: Establish processes to ensure data quality control, processing of raw data, and preparation
of data sets for more extensive analysis and statistical modeling.
SPECIFIC AIM 4: Evaluate, assess and implement new cutting-edge technologies for molecular phenotyping.